University of Colorado Population Center

DEVELOPMENT CORE
PROJECT SUMMARY
The Development Core represents an important component of the University of Colorado’s
Population Center (CUPC) proposal in response to RFA-HD-20-015 for the Population
Dynamics Research Infrastructure Program FY 2020 (P2C). CUPC requests renewal of
infrastructure support for the five-year project period 2020–2025. Fueled by NICHD funds, the
Center is firmly established as the hub of population science at CU and CUPC’s Development
Core has been redesigned to build on CUPC’s strong momentum.
In the next five years, the Development Core has three specific aims: (1) increase the scientific
impact, innovation, and productivity of CUPC's population researchers; (2) increase CUPC
affiliate's competitiveness for external funding in population science; and (3) continue and
increase support for early investigators in population science. A variety of new and reconfigured
activities are proposed to meet these aims. To enhance productivity and innovation, as well as
to increase cohesiveness within primary research areas, in the past five years, thematic working
groups have been established with faculty leads. These groups have had notable success in
spurring new research collaborations and in the next grant cycle, resources are requested to
support innovative activities within the working groups. Also, to increase external funding
competitiveness, CUPC will develop a grant writing workshop to build on the already-impressive
success of the Center’s energetic, early stage investigators. Finally, substantial new investment
from CU Boulder provides resources to raise the funding on seed grants and increase the pool
of available funds. Throughout, the CUPC director and Development Core director collaborate
to ensure that early stage investigators are centrally considered within investments with a target
of this group receiving at least 50% of seed grants in the next five years.
Faculty accomplishments have been recognized at the university scale as evidenced by
generous, new support from across the Boulder campus. A formalized Memorandum of
Understanding with CU Denver expands the Center with new funding, space and collaborative
commitment. These combine to lay a foundation for CUPC’s continued growth in productivity,
innovation and impact and the Development Core has been redesigned to support the Center in
this growth.